Cellular and Molecular Mechanisms of Ear Morphogenesis

Project Summary/Abstract Development of the complex three-dimensional structure of the inner ear requires precise coordination of cell fate specification, proliferation, survival, and morphology. Even subtle failures during one developmental process can have catastrophic consequences. Indeed, many human deafness and balance disorders are caused by defects in the development of the auditory system, ranging from a complete loss of the semicircular canals or cochlea to auditory circuitry deficits that interfere with sound perception. The long term goal of our work is to understand how genetic mutations lead to changes in the structure and function of the inner ear, ultimately resulting in deafness and vestibular dysfunction. One of the enduring mysteries in our field is how three hollow semicircular canals are formed from an initially simple sphere of epithelium. A key step in this process is a fusion event that eliminates cells in the center of a canal pouch while leaving the surrounding canal rim intact. Although Netrin1 (Ntn1) and FGF proteins are involved, very little is known about how these secreted proteins interact to determine when and where fusion occurs. We have defined a novel pathway for canal morphogenesis. We found that the Ig superfamily protein Lrig3 participates in reciprocal interactions with Ntn1 that ultimately restrict fusion to the center of the pouch. Lrig3 is a poorly characterized transmembrane protein with leucine rich repeats (LRR) and immunoglobulin (Ig) domains in its extracellular domain. While Lrig proteins are able to antagonize receptor tyrosine kinase (RTK) signaling in some contexts, how this occurs at the molecular level is not known. Since FGF receptors are RTKs and can bind to Lrig3, we hypothesize that Lrig3 provides a link between FGF signaling and Netrin1 during canal morphogenesis. Further, we propose that all three Lrig proteins share a common ability to fine tune FGF and other signaling pathways elsewhere in the developing and mature inner ear. In support of this idea, Lrig1 and Lrig2 are also expressed in the inner ear and are required for hearing. In this study, we will complement phenotypic analysis in mice and chicks with biochemical investigations of Lrig, FGFR, and Ntn proteins in order to gain insights into the cellular and molecular mechanisms that govern inner ear development. Specifically, we will ask 1) Does Lrig3 act through an FGF signaling pathway to regulate Ntn1 expression? 2) What are the subsequent consequences of Ntn1 activity at the cellular level? and 3) Do Lrig proteins share a role in receptor trafficking that influences other aspects of inner ear development? These studies will improve our knowledge of the cellular and molecular basis of ear morphogenesis and elucidate the functions of Ntn and Lrig proteins, which have been implicated in tumor formation and invasion in humans.

Public health relevance
Project Narrative Many human deafness and balance disorders are caused by genetic mutations that disrupt development of the inner ear, an intricate structure that houses specialized cells for the detection of sound or motion. An effective approach toward understanding the origins of human inner ear defects is to identify genes that are required for inner ear development in animal models. A thorough knowledge of how these genes direct formation of the inner ear in mice will facilitate the identification of deafness genes in humans, improve detection and diagnosis of human deafness and balance disorders, and uncover new targets for therapeutic intervention. __SpecificAimsTextDelimiter__ Specific Aims Hearing and balance require perfect formation of the intricate structure of the inner ear. Many human deafness and balance disorders are caused by genetic mutations that disrupt diverse aspects of inner ear development, from malformation of the cochlea to miswiring of auditory circuits. During development, multiple signaling pathways cooperate to transform the otic vesicle into a complex structure with three semicircular canals oriented with the three dimensions of space and a properly coiled cochlea. The canals are sculpted from epithelial pouches that extend from the otic vesicle (Fig. 1). Fusion plate cells in the center of each pouch express the secreted protein Netrin1 (Ntn1) and lose their epithelial morphology. At the same time, the basement membrane (BM) surrounding the fusion plate is disassembled, allowing signals from the epithelium to induce proliferation of the surrounding mesenchyme. The fusion plate cells subsequently disappear through an unknown mechanism, leaving the remaining non-fusing cells to form the rim of the mature canal. Hence, the shape of each canal is determined by where fusion occurs. However, apart from genetic evidence that Netrin1 and FGF signaling is required, little is known about the molecular pathways that control fusion. We discovered that the Ig superfamily protein Lrig3 is a novel regulator of canal fusion (Abraira et al., 2008). In Lrig3 mutant mice, the lateral semicircular canal is truncated because cells in the canal rim fuse and disappear. This is due to ectopic expression of Ntn1, which causes early and expanded breakdown of the BM. Conversely, Ntn1 represses expression of Lrig3. Through these mutually inhibitory interactions, Ntn1, and hence BM breakdown, is restricted to the fusion plate. Lrig genes encode evolutionarily conserved transmembrane proteins with unusual extracellular domains consisting of fifteen leucine-rich repeats (LRR) and three immunoglobulin domains (Ig). Although their molecular functions remain obscure, Lrig1 has been shown to bind to and inhibit several receptor tyrosine kinases (RTK). We showed that Lrig3, like Lrig1, binds to and co-localizes with RTKs in intracellular vesicles in vitro, suggesting a common role in trafficking (Abraira et al., 2010). However, the RTK that is relevant to the Lrig3 inner ear phenotype remains elusive. Since Lrig3 binds to and downregulates FGFR in vitro and FGF signaling is required for canal fusion, we propose that Lrig3 regulates fusion by inhibiting FGFR. Specifically, we propose that an FGF signal induces expression of Ntn1, and that Lrig3 ensures that this signal is restricted to the fusion plate. Our specific aims are: Aim 1: To test whether Lrig3 regulates Ntn1 expression via modulation of FGF signaling We propose that FGF signaling induces the fusion plate, and that this signal is modulated by Lrig3. If this model is true, then overexpression of Lrig3 should block FGF signaling and inhibit Ntn1 expression. Conversely, constitutive activation of FGFR should recapitulate the Lrig3 mutant phenotype, while fusion should be arrested in FGFR knock-outs. We will test these ideas using Cre-lox technology in the mouse. . These experiments will reveal whether Lrig3 acts through FGFR as well as the specific contribution of FGF signaling to the fusion process. Aim 2: To dissect the cellular functions of Netrin1 during canal fusion A key step in fusion is the breakdown of the BM that separates the fusion plate epithelium from the surrounding mesenchyme. Ntn1 plays a critical role in this process: ectopic Ntn1 causes expanded BM breakdown, while breakdown fails to occur in Ntn1 mutants. Ntn1 is a multi-domain protein that mediates its effects in the BM through unknown receptors. To better understand the basis of Ntn1-dependent BM breakdown, we will use viruses to overexpress Ntn1 in the chick otic vesicle. Infected ears will be assayed for changes in canal structure, cell fate, cell morphology, and BM integrity. We will then perform a structure-function study to identify the domains that mediate these effects. Aim 3: To characterize a role for Lrig proteins in receptor trafficking Since little is known about the molecular properties of any Lrig protein, how Lrig3 might fine tune FGF receptor activity is unclear. We hypothesize that Lrig proteins control the subcellular distribution of RTKs, including FGFR. In support of this idea, in vitro studies show that all three family members are present on the cell surface and in intracellular vesicles, where they co-localize with RTKs. We will use newly generated antibodies to test whether Lrig proteins are also present in intracellular vesicles in vivo, together with live imaging of spiral ganglion neurons to determine whether Lrig proteins follow a route consistent with endocytosis and degradation. We will then define the motifs that determine this subcellular distribution, as well as those that mediate interactions with FGFR. Finally, we will test whether these shared motifs reflect a common underlying cellular function by analyzing Lrig1;3 double mutant mice. Since Lrig1 and Lrig2 are also expressed in the inner ear and are required for hearing, a better grasp of the cellular and molecular functions of Lrigs will not only inform our work on canal development, but will also provide insights into additional aspects of inner ear development and function.